Mapping Fitness & Free Energy Landscapes of Proteins

Project Summary/Abstract
Our goal is to integrate structure and sequence-based approaches grounded in statistical mechanics to
understand key features of molecular recognition by proteins, as well as protein fitness and function more
generally. There are three aims. The first is focused on mapping complex conformational and fitness landscapes
of proteins. We will integrate machine learning (ML) sequence co-variation and molecular dynamics structure-
based approaches to analyze the sequence dependent conformational landscapes of proteins with a particular
focus on the landscapes that govern the transitions of kinase family proteins from the active to functionally
important inactive states. With our collaborators we will investigate the sequence dependent origin of the
alternative binding modes for peptide substrates that TKs have compared with STKs. This work has important
implications for the design of therapeutics targeting Src and other cytoplasmic TKs which appear to bind peptide
substrates in an unusual way. Also, as part of our first aim, we will map the free energy landscape of the set of
kinase P-loop active conformational states; this information is needed for efforts to develop anti-cancer
therapeutics with higher specificity. The thrust of the second aim is to realize the power of the sequence-
covariation ML methods we are developing to detect and decompose multi-residue allosteric interaction motifs
within kinases and kinase protein complexes by evaluating connected mutational correlations that carry
signatures of indivisible units of biological information flow. These methods are designed to identify allosteric
pathways and will be generalizable to other protein targets we are working on including GPCRs and the HIV
Intasome. Our third aim is to build on the structure-based molecular dynamics approaches we recently
developed to determine the excess chemical potential of water molecules at the surface of proteins. The excess
chemical potential provides quantitative information about position specific thermodynamic features of interfacial
water molecules and their networks. Together with our experimental Cryo-EM collaborators we will use this
information to refine solvent at the protein-solvent interface in Cryo-EM density distributions in an iterative and
self-consistent way; this will substantially improve upon current methods for locating and refining solvent in Cryo-
EM maps of proteins and their assemblies. This new refinement tool will be made available to the structural
biology community. We will build on our recent development of classical density functional methods to evaluate
how the displacement of specific solvent molecules located in protein binding sites affects the affinities and
specificities of the small molecule ligands targeting these sites.

Public health relevance
Project Narrative This proposal is focused on the development and application of novel computational methods to map the free energy and fitness landscapes of proteins, with a focus on protein kinases (PKs) which are involved in many cellular signaling pathways. Our goal is to construct an atlas representing key features of the conformational landscapes of PKs using sequence co-variation models and molecular dynamics simulations in an integrated way. This information provides a foundation for understanding the molecular basis for their biological function, how and why mutations cause disease states, and provides insights into the design of therapeutics.